Novel Characterization and Detection Techniques for Acute Myocardial Ischemia

2 Abstract
The most common reason for a patient to visit the emergency department is chest pain caused by myocar-
dial ischemia. Myocardial ischemia develops from inadequate perfusion of myocardial tissue and indicates the
presence of surprising range of conditions, including coronary artery disease, coronary microvascular dysfunc-
tion, Takotsubo cardiomyopathy, and coronary artery dissection, and other potentially fatal cardiac diseases.
Current noninvasive tests to detect ischemia may be limited by an incomplete understanding of the mecha-
nisms used to induce the stress (exercise or pharmacological agents) or the limited diagnostic data acquired
to visualize ischemia (12-lead electrocardiogram or ultrasound). These limitations increase the risk for failed
detection of deadly cardiac diseases and explain the unsatisfactory accuracy of current diagnostic and monitor-
ing approaches. The goal of this project is to leverage recent experimental ﬁndings and breakthroughs about
the onset and progression of ischemia as the basis for a comprehensive re-evaluation of acute myocardial is-
chemia. We will develop and use experimental models and computer simulations to devise better techniques
to detect acute myocardial ischemia and localize it within the ventricles. We will build on our experience with
our novel large-animal experimental models of ischemia and electrocardiographic imaging (ECGI) techniques
to measure and characterize the electrical changes that arise during acute myocardial ischemia created from
various types of ischemic stress. We will use these measurements to characterize different types of cardiac
stress and implement novel ECGI techniques to detect and localize ischemic sources within the heart.

Public health relevance
3 Narrative Myocardial ischemia arises under conditions of inadequate blood supply to the heart and is associated with a surprisingly broad range of conditions, such as coronary artery disease, ischemic cardiomyopathy, or coronary artery dissection. The most common symptom—chest pain—is also the most frequent reason for visits to the emergency department of hospitals. The goal of this project is to create and validate, through controlled exper- imental preparations and computer modeling approaches, a painless, inexpensive, and noninvasive detection system based on the electrocardiogram to localize regions of myocardial ischemia within the heart.